Decoding Influenza-Induced Damage: What's all the Hyp(oxia) about?

PROJECT SUMMARY
Influenza viruses cause seasonal and epidemic outbreaks that pose a recurring burden on global public health
systems. Despite annual vaccination efforts, severe influenza virus infections occur each year and
disproportionally impact children, the elderly, and those with pre-existing conditions. Influenza-induced lung
damage and persistent inflammation are highly variable across infected individuals, with limited understanding
of the pathogenic signals that contribute to these processes. This proposal hopes to shed light on the pathogenic
signals that promote the development of damage-associated niches in the lung leading to more severe disease
outcomes. Prior members of the Thomas laboratory discovered a subset of damage- responsive fibroblasts
(DRfibs) that reside in damage-associated lung niches and uniquely contribute to influenza-induced lung
damage. DRfibs produce high levels of ADAMTS4, an enzyme that degrades versican, an extracellular matrix
component produced in the lung during development and infection. Interestingly, when mice lack ADAMTS4,
they are protected from influenza-induced mortality compared to wildtype littermate controls. It was found that a
dense versican barrier prevented CD8 T cell: DRfib crosstalk, leading to fewer IFNg-producing CD8 T cells, less
lung damage, and improved hypoxemia in ADAMTS4 KO mice. This proposal seeks to exploit ADAMTS4 KO
mice as a model of damage-associated niche disruption to elucidate how preventing T cell: DRfib communication
affects T cell phenotype, clonality, and specificity using spatial transcriptomic, scRNAseq, and TCR sequencing
approaches. Low blood oxygen saturation (hypoxemia) is included as a predictor of poor outcomes in 9 out of
12 influenza and pneumonia severity scores, highlighting a strong correlation between impaired oxygenation and
influenza severity. Tissue-level hypoxia in the lungs is also a characteristic of influenza illness. Previous research
has shown that a cell’s microenvironment can significantly impact its phenotype; however, the impact of hypoxia
on immune and stromal cell subsets in the lungs during and following a respiratory virus infection has not yet
been explored. This F32 proposal will employ a unique mouse model to reveal how hypoxia in the lung
microenvironment during severe respiratory viral infection influences the phenotypes of T cells and fibroblasts.
Successful completion of the proposed will generate a unique atlas of hypoxic cell phenotypes that could have
broad implications for the field as many severe respiratory viruses induce hypoxemia and lung damage. Dr. Paul
G. Thomas, a well-established influenza immunologist and member of the Center of Excellence for Influenza
Research and Response, and St. Jude Children’s Research Hospital will be integral to achieving the goals
outlined in this proposal by providing technical training, practice in scientific communication, mentorship
experience, on-site access to state of the art resources, and networking opportunities with influenza experts.
Completion of the research and training goals outlined in this F32 proposal will unveil novel mechanisms of
influenza pathogenesis while supporting the development of the applicant’s independent research career.

Public health relevance
PROJECT NARRATIVE Hypoxemia and lung hypoxia are features of severe influenza infections. Hypoxia is present in influenza infected lung tissue but how a hypoxic microenvironment impacts the phenotype of immune and stromal cells that reside within these niches has yet to be elucidated. I hypothesize that hypoxia contributes to lung damage perpetuation during severe influenza infection by promoting pathogenic T cell and fibroblast phenotypes.